Adaptation and implementation of a patient navigation program for cervical cancer screening across contexts in Senegal

PROJECT SUMMARY ABSTRACT
Cervical cancer mortality is expected to increase by 42% to 442,926 deaths worldwide by 2030. Currently
85% of incident cervical cancers and 87% of cervical cancer deaths occur in low- and middle-income countries
(LMIC). Due in large part to the low utilization of cervical cancer screening services, Senegal ranks 17th in the
world for cervical cancer incidence. For women ages 40 to 49 in rural regions of the country the cervical cancer
screening rate is very low at less than 2%. As a result women often present with mostly preventable late stage
cancers. Secondary prevention programs (cervical cancer screening) are critical to effectively achieving global
progress toward the elimination of human papillomavirus related cancers. However, considerable context
variation across geographic- and health system-levels in LMICs markedly obstructs the community
responsiveness of an implemented program. Lessons learned from higher resource countries show that
incidence and mortality rates decline and early deaths are prevented with early detection and appropriate follow-
up and treatment. Prior efforts and pilot studies in Senegal show that there is slow uptake, poor follow-up, and
low treatment rates for women who are screened positive.
Patient navigation is a strategy to eliminate barriers to screening, timely diagnosis, and follow-up to
improve cancer outcomes in vulnerable populations. In high-income countries, patient navigation has
demonstrated considerable effectiveness in its ability to address communication, information, medical system,
and emotional barriers to timely care across all phases of the cancer care continuum, including detection,
diagnosis, treatment, and post-treatment quality of life. Patient navigation programs enhance access to care,
promote self-efficacy, and sustain patient engagement with care, and have been shown to improve cancer
outcomes, particularly among marginalized groups, rural populations, and impoverished communities.
The goal of this project is to prevent unnecessary deaths due to cervical cancer in Senegal. This mixed
methods research responds to identified intrapersonal- and community-level barriers to early cervical cancer
screening uptake, follow-up, and treatment among women there. We will apply the Dynamic Adaptation Process
to study the adaptation of an evidence-based cervical cancer patient navigation program in urban and rural
contexts of Senegal, measure the intervention effectiveness, and evaluate programmatic implementation
outcomes. By studying the process of adaptation of a patient navigation program in a low- and middle-income
country, we will apply implementation science to a novel context. With a particular focus on how the adaptation
responds to cancer-related stigma and women’s autonomy in healthcare decision-making, our project
demonstrates additional innovation. The process knowledge generated will further our long-term goal to inform
the national cervical cancer prevention and control programs in Senegal and other low- and middle-income
countries.

Public health relevance
PROJECT NARRATIVE Cervical cancer mortality is expected to increase by 42% to 442,926 deaths worldwide by 2030 with 87% of cervical cancer deaths occurring in low and middle income countries. Patient navigation programs enhance access to care, promote self-efficacy, and sustain patient engagement with care, and have been shown to improve cancer outcomes, particularly among marginalized groups, rural populations, and impoverished communities. This research will contribute to the critical gap in the scientific literature describing the adaptation of cervical cancer patient navigation strategies to optimize programs across local contexts in low- and middle- income countries.